Sensor and Hazard Simulator for Large Scale Field Exercises (Phase II)

Summary/Abstract - Sensor and Hazard Simulator for Large-Scale Field Exercises (Phase II)
HAZMAT incidents can be classified as small scale and large scale. A small-scale incident involves one or more hazards
whose exposure to each can be modeled as a function of distance between the worker and a point source, such as a
leaky valve on a pressurized canister or small hole in a barrel. A large-scale incident involves a hazard that covers a wide
area and cannot be modeled by a point source, such as a large spill or contaminated floodwaters. The number of large-
scale incidents has increased by 33% in 8 years, highlighting the need for realistic large-scale incident training exercises.
HAZMAT instructors and training program administrators acknowledge that field exercises are important to learning
HAZMAT skills, including detecting and identifying hazards, working while wearing protective equipment (PPE), and
delineating exclusion, contamination, and support safety zones. A goal of these exercises is to present learners with
realistic tasks and experiences involving mock hazards, PPE, tools, and chemical and radiological sensors. However,
while PPE, tools, and mock hazards are readily available to instructors, sensors that operate with large-scale mock
hazards are not available. The decisions made by a HAZMAT worker, e.g., identifying hazards, establishing safety zones,
and selecting command and decon sites, require exposure readings from sensors. Consequently, making and
interpreting sensor readings are critical skills, and the ability of a HAZMAT trainers to teach these skills is significant.
Cell Podium proposes an SBIR Phase II effort for the development and evaluation of a low-cost simulation system that
enables trainers to conduct HAZMAT field exercises with multiple realistic mock sensors and small and large scale
chemical and radiological hazards without the need of installing software or hardware. The system exploits recent
developments in sub-meter geolocation and browser-based mobile computing, uses CAMEO physics modeling, and is
one of the first HAZMAT training applications of the new multi-band GNSS receiver chips with < 1 feet accuracy
appearing in cell phones.
Phase I efforts focused on assessing the field exercise requirements of instructors of HAZMAT workers and responders,
and empirically verifying that GNSS can satisfy the spatiotemporal resolution requirements of realistic sensor simulation.
Phase II efforts will yield several iterations of a minimum viable product (MVP) of the system, each based on feedback
from six HAZMAT training organizations that will use the MVP in their HAZMAT field exercises, including schools of
public health, rural and urban community organizations, and the US Air Force. The diversity in the organizations’
missions, operating styles and training requirements supports the collection of requirements and feedback representing
the broader HAZMAT training community. In order to promote the research translation of the Phase II results, Cell
Podium will present interim and final Phase II results at the semiannual conferences of the National Institute of
Environmental Health Sciences (NIEHS) Worker Training Program (WTP), in which organizations from around the country
participate to learn new HAZMAT training techniques.

Public health relevance
Narrative - Mixed-Reality Sensor and Hazard Simulator for Large-Scale Field Exercises The actions selected by a HAZMAT worker are often dictated in real-time by the readings from chemical and radiological sensors; consequently, knowing how to make and interpret such sensor readings are critical life-saving skills in man- made, environmental, and weather-related incidents. Using advanced low-cost assets, this project will cost-effectively introduce the realism of mixed reality to experiential HAZMAT training that supports the development and evaluation of these skills. In particular, the project prototypes and deploys to operational training programs a browser based mobile device solution for large-scale HAZMAT training exercises that simulates different handheld sensors and displays realistic exposure levels taking into account the presence of all the mock hazards deployed in the exercise, and their type, leakage, and safety zones.